Identification of the active nuclear niche(s) using novel proteomic, genomic, transgenic, and live-cell microscopy technologies

The study of gene expression and possible role of condensates in regulating gene expression have
largely ignored known nuclear structures. This proposal is significant because we propose a novel model for
the role of nuclear organization in regulating gene expression: 1) Nuclear speckles and still unknown nuclear
compartments/bodies help organize other phase-separated condensates to modulate gene expression; 2)
Nuclear speckles together with surrounding nuclear compartments/bodies and associated phase-separated
condensates together represent active nuclear niches which may have different functional properties; 3) Small
distances matter: gene movements of only a few hundred nm between repressive and these different active
nuclear niches may differentially regulate gene expression; 4) Action-at-a distance: component flux into and
out of these nuclear compartments will have global effects on gene expression; 5) These same nuclear
compartments/bodies may similarly modulate RNA processing and organize nuclear export.
Here we propose to: 1) Identify multiple components of known and still unknown nuclear “active
niches”; 2) Map genome-wide the positions and predicted movements of genes relative to these active niches
during physiological transitions; 3) Visualize nuclear body/compartment dynamics and fluxes of proteins
between nuclear bodies in steady-state and through physiological transitions; 4) Visualize movements of
reporter transgenes, endogenous genes, and rewired chromosome loci relative to these nuclear
bodies/compartments and temporally correlate changes in gene expression with their dynamic movements and
compartment associations; 5) Visualize movements of pre-mRNAs and nuclear mRNAs during RNA
processing and export; 6) Measure fluxes of nuclear body components to and from adjacent transcribing
chromatin. Additionally, we propose developing relatively low-cost, novel microscope platforms and software
specifically designed to facilitate these live-cell imaging goals in our laboratories as well as others.
Our Aims will be to: 1. Map proteins, genes, RNAs relative to active nuclear compartment(s) using
iterative rounds of TSA-MS-Ratio, validation by light microscopy, and TSA-Seq; 2. Measure dynamics of
bodies, components of nuclear bodies using live-cell imaging; 3. Measure temporal correlation between
changes in gene expression and gene movement relative to nuclear bodies and visualize the export path of
expressed transcripts; 4. Design and deliver two novel microscopes designed to facilitate Aims 1-3 at a
modest cost. Successful completion of these Aims should significantly change our current understanding of the
role of nuclear organization in regulating gene expression with impact across a wide range of research fields.

Public health relevance
The functional relationship between nuclear compartments and gene expression remains an enigma. Here we propose to identify components of known and still unknown nuclear “active niches”, using a novel combination of proteomics and omics proximity-labeling. Live-cell imaging will then determine the movements of genes and mRNAs to and from these active niches and determine the functional significance of these movements on gene expression exploiting the design of novel, low-cost, high-end microscopes.